Defining and targeting the compartmentalization of redox metabolism in aging using novel genetically encoded tools

Abstract Multiple lines of evidence designate mitochondrial dysfunction and related cellular reduction-oxidation (redox) imbalance as one of the hallmarks of aging. The redox cofactor nicotinamide adenine dinucleotide (NAD+) plays a central role in cellular energy metabolism, and it is an essential cofactor for supporting mitochondrial oxidative phosphorylation (OXPHOS). Numerous studies have implicated lowering cellular NAD+ levels in aging- associated metabolic changes, but its precise role at present remains contentious. This is mostly because NAD+ and its phosphorylated form NADP+ are substrates in hundreds of redox reactions which are often times performed by paralogous enzymes found in different cellular compartments. Compartmentalization of cellular metabolism is one of the most fundamental properties of complex eukaryotic life and in order to support healthy cellular functions many metabolic pathways are spatially and temporally compartmentalized. To our knowledge, there have not been any comprehensive studies of the compartment-specific redox metabolism of the aging process, and the NAD+ cofactor is viewed only as a substrate for “NAD+-consuming” or signaling enzymes which are involved in epigenetic modifications (sirtuins) and DNA repair (poly(ADP-ribose) polymerase), widely ignoring its role in redox reactions. We recently developed genetically encoded tools which can be used to increase the NAD+-to-NADH or NADP+-to-NADPH ratios in the cytosol or mitochondria in mammalian cells. In this application we propose to study the role of redox compartmentalization in aging by expressing our tools in different cellular compartments (nucleus, cytosol, mitochondria, endoplasmic reticulum and peroxisomes) of both human primary fibroblasts and the multicellular nematode C. elegans. In both model systems we will explore how an increase in the NAD+-to-NADH or NADP+-to-NADPH ratios in different compartments tracks with cellular senescence, stress resistance and lifespan. Our current approach, for the first time, will allow us to identify both NAD- and NADP-coupled redox pathways or mechanisms which play key roles in the regulation of aging.

Public health relevance
Project narrative Recently there has been an explosive increase in interest by both the general public and the research community in identifying small molecules which can increase cellular nicotinamide adenine dinucleotide (NAD) levels to promote beneficial effects on healthspan. It is presently unclear how NAD and its phosphorylated form (NADP) are implicated in the regulation of the redox environment in the context of aging-associated metabolic changes. We propose to develop tools and reagents that will facilitate the detailed investigation of the contributions of NAD and NADP redox metabolism to aging-associated phenotypes seen in both primary human fibroblasts and multicellular nematodes.